XV Progress in Motor Control Conference

PROJECT SUMMARY
Motor Control is a pivotal discipline exploring how the central nervous system (CNS) enables humans and also
animals to execute motor behaviors. The Progress in Motor Control (PMC) Conference is a premier international
platform for fostering interdisciplinary dialogue in movement studies. Now in its fifteenth iteration (PMC XV), the
conference will be hosted by the University of Rhode Island in conjunction with the International Society of Motor
Control. The event will take place at the University of Rhode Island, Kingston (RI), from June 30 to July 2, 2025,
offering attendees opportunities for intellectual exchange amidst the scenic backdrop of Newport, known for its
rich maritime heritage.
PMC XV will bring together researchers, educators, and practitioners to integrate insights from Anatomy,
Physiology, Biomechanics, Computational Neuroscience, Bioengineering and Rehabilitation Science. It will
feature sessions addressing foundational and translational research in motor control, with themes including:
• Theories of Motor Control and Learning: Models and adaptive strategies for individuals with motor
disorders or injuries.
• Neural Control of Movement: Mechanisms underlying planning, execution, and coordination of voluntary
and involuntary actions.
• Advances in Rehabilitation Neuroscience: Bridging experimental neuroscience with clinical applications
to improve outcomes for individuals with motor dysfunctions.
The conference will host 35 invited speakers. These experts will present on topics ranging from computational
frameworks to real-world applications in motor control. Networking opportunities and community-building
activities will include sailing, Newport tours, and a formal dinner, fostering collaboration among participants.
PMC XV will also support the development of emerging scholars, offering travel grants to pre- and postdoctoral
trainees to promote accessibility and diversity (10 students). Special efforts will ensure inclusivity for
underrepresented groups, including minorities, women, and individuals with disabilities.
Several networking events will also be organized in order to maximize opportunities for students and young
investigators to interact with established researchers and to involve minorities and women and individuals with
disability in this event. The growing need for translational approaches that can benefit individuals with motor
disorders highlight the relevance of this proposal.

Public health relevance
PROJECT NARRATIVE Only in the US movement disabilities affecting more than 18 million individuals annually, which highlight the urgent need for effective treatments, making motor control a crucial discipline in understanding the neural mechanisms of movement in health and disease. This funding application aims to support 10 pre- and postdoctoral travel grants for trainees and partial travel support for 35 invited speakers to attend the XV Progress in Motor Control Conference, held at the University of Rhode Island, Kingston (RI), from June 30 to July 2, 2025. The conference will unite experts across disciplines, including anatomy, physiology, computational neuroscience, bio-engineering and therapeutic research, fostering interdisciplinary collaboration and driving advancements in movement science.